PROTEIN METABOLISM IN UREMIA--THE CATABOLIC EFFECTS OF HEMODIALYSIS

Effects of hemodialysis membrane on leucine turnover, urea kinetics, and nitrogen excretion in patients with chronic renal failure.